Stochastic Simulation Of Excitation-contraction Coupling

SUMMARY OF WORK As a result of extensive collaboration with Clara Franzini-Armstrong we have obtained extensive statistical data on the distribution of organelles and ryanodine receptors in rabbit siono-atrial node cells. These data indicated that the parameters of our 3D stochastic SANC model need to be extensively revised. However, the EM data are not sufficient to define the critical distribution of ryanodine receptors on the cell surface. We have done extensive imaging using ultra-resolution SIM microscopy, and have developed software that enables 3D reconstruction of the location and size of ryanodine receptor clusters, which will be used directly in the model. We are currently developing software that will use 1000 processors to model the shape and Ryr distribution of individual cells. We have developed software that can detect, classify and track calcium release event in 3D+time, both in simulations and in experimental records. This has led to new understanding of the way that propagation occurs in the model as a function of adrenergic stimulation, and to the discovery that there are many more release events in experimental records than previously suspected. We have begun studies of heterogeneity of cells within the sinus node, both in isolated cells and in high space and time resolution images of whole sinus node preparations from mouse. We have extended the 3D stochastic model to multiple, interacting cells. In the next program period we will attempt to model the way that heterogeneous interacting cells give rise to the heart rhythm as an emergent property. We have also initiated a new study that applies statistical physics methods from solid-state theory to the interactions of clustered ryanodine receptors. This has shown that the process of EC coupling involves two different phase transitions that can be modeled analytically. As advised by the Board of Scientific Counselors, we are undertaking to translate our extensive modeling software into a form that can be used by other investigators. This has been complicated because the model software in written in the computer algebra language Macsyma whose commercial form is no longer available. To solve this problem we undertook a 4 month project in collaboration with some of the original developers of the language to upgrade the free, open-source version (called Maxima for copyright reasons) so that it can process our modeling software. This upgrade has now been incorporated in the latest version of Maxima (Sourceforge.com) so that our modeling suite can now be published and used by others.

We have updated and extended our modeling of the sino-atrial node (pacemaker) of the heart:
(1) The 3D stochastic simulation of single sino-atrial node cells has been updated to include realistic gating schemes for the L-type calcium channels based on recent work at Johns Hopkins. The model now includes two types of L-type channels and different locations of the channels in the cell.
(2) We have extended models based on calciun-release units to be a full model of the coupled-clock mechanism which can be run much faster than the full 3D model. This work has been recently published in Journal of General Physiology.
(3) We have developed a large scale model of the multi-cellular node at a single-cell resolution that will make possible comparisons with experimental data on the structure of the node.

Experimentally, we have used mice with green fluorescent protein linked to the ryanodine receptor to demonstrate that propagated local calcium releases are due to calcium sparks "jumping" in saltatory propagation by diffusion of calcium. This finally confirms experimentally the paradigm that underlies all of our simulations of sinus node cells over the past 7 years.

During the last project period, we have extended the fast, calcium release unit model to a full model of the sinoatrial cell and used that model to explore the effect of calcium release unit distribution in space. At the same time we completed extensive analysis of the SIM images to determine the actual distribution of release units in more than 100 cells each from young and old mice and rabbits. This information has been incorporated in the CRU-based fast model and in the full simulation at the level of individual ion channels. Simultaneously, Alex Maltsev of our group has developed advanced statistical methods to detect and classify functional modules in the intact sinoatrial node, and a novel algorithm to generate cell networks for simulation of these modules. We have shown, using the full 3D sinoatrial cell model that dormant cells can collaborate to generate a pacemaker module without a dedicated pacemaker cell.

During the most recent project period we have extended the full 3D sino-atrial cell model to incorporate the distribution of couplons found by SIM microscopy, which required extensive use of parallelization methods to account for couplons crossing boundaries between processors. The model of the L-type calcium channels has been extensively revised to incorporate thermodynamics of allosteric coupling of voltage sensors and calmodulin, yielding Markov models with 1024 states for each channel. We have carried out extensive voltage clamp measurements to characterize the ensemble currents of L-type channels and are developing machine-learning software to fit the parameters of the new L-type model. We are undertaking d-STORM ultra-resolution microscopy in order to establish the relationship of channel types in the couplon of sino-atrial node cells, which has never been determined.

In a new effort, we have made extensive studies of the role of stochastic resonance in the activation and recovery of beating in the sino-atrial node. These studies have revealed that these cells of a capability of remembering their former state. In the next project period we will try to establish the role of different organelles and reactions in this memory which may be critical to recovery of the heartbeat after stress.